The role of rapid estrogen signaling in alcohol drinking behavior

Project Summary/Abstract
Binge alcohol drinking is a major risk factor for many diseases, including alcohol use disorder (AUD) and other
neuropsychiatric diseases, and women are at greater risk for developing AUD than men with the same history
of alcohol use. The sex hormone estrogen, which fluctuates across the menstrual/estrous cycle in females, has
been implicated in playing a regulatory role in alcohol drinking behavior across mammalian species, but the
specific mechanisms underlying this function are not well understood. We recently found that ovarian estrogen
acts via rapid, nongenomic signaling at membrane-associated estrogen receptors in the limbic system to drive
binge alcohol drinking behavior in gonadally intact female mice. We hypothesize that estrogen regulates
presynaptic neurotransmitter release and postsynaptic excitability in a coordinated fashion to regulate the
activation and signaling of critical neuropeptidergic circuits that promote alcohol use. In the proposed work, we
examine the circuit and receptor signaling context for rapid E2 modulation of neuronal function that drives
binge alcohol drinking in intact female mice. These studies will improve our understanding of this behavior in
females, potentially providing new avenues for pharmacotherapeutic approaches to curbing excessive alcohol
consumption.

Public health relevance
Project Narrative Binge alcohol drinking is a major risk factor for neuropsychiatric diseases including alcohol use disorder, and women are more likely to develop these diseases with a shorter history of alcohol consumption and suffer greater negative effects of binge drinking. The research proposed here will characterize the mechanisms by which the sex hormone estrogen dynamically controls alcohol drinking behavior in female mice through rapid modulation of critical brain circuits in real time. This work may identify novel targets for intervention and prevention of excessive alcohol drinking, especially in women.